The impact of early life stress on vascular aging

Project Summary
This project aims to explore how early life stress (ELS) and adversity contribute to cardiovascular
disease (CVD) risk in adulthood using a preclinical mouse model. Clinical research demonstrates
that ELS accelerates aging processes and increases susceptibility to neurodegenerative,
cardiovascular, and metabolic diseases, with a particular focus on vascular dysfunction. However,
the complex behavioral and social factors associated with ELS make it difficult to pinpoint specific
mechanisms linking ELS to CVD. Using a multi-disciplinary approach, this proposal addresses
this gap by investigating how ELS affects cardiovascular structure, function, aging, and future
CVD risk. The project will examine two specific objectives using an animal model of early life
adversity. (Aim 1) Evaluate the effects of early life adversity on vascular structure and function in
adulthood. (Aim 2) Investigate vascular molecular changes in adulthood due to early life adversity.
This study will advance understanding of how ELS influences adult CVD risk, identify potential
sex-specific vascular markers, and provide insights into therapeutic targets for CVD linked to
early-life adversity.

Public health relevance
Narrative: Despite extensive clinical data, understanding early life stress (ELS) impact on cardiovascular function, particularly vascular aging, remains limited. To bridge this gap, our interdisciplinary MPI team will investigate whether ELS accelerates vascular aging and elucidate underlying mechanisms, aiming to uncover specific biomarkers of resilience and potential interventions for ELS cardiovascular aging related disease.